Psilocybin effects on brainwide activity dynamics supporting accelerated task acquisition

PROJECT SUMMARY / ABSTRACT
This proposal aims to investigate the systems-level brain mechanisms underlying the therapeutic potential of
psilocybin, a psychoactive compound that has attracted recent attention for the treatment of anxiety,
depression, addiction, pain, and illness-associated distress. Despite promising outcomes in clinical trials, the
specific mechanisms governing psilocybin's medicinal effects remain poorly understood. Our preliminary data
reveal a novel dissociation between two major effects of a single dose of psilocybin: serotonergic receptor
activation mediates acute behavioral changes, while BDNF/TrkB signaling drives improvements in learning and
motivated behavior lasting for weeks after a single dose of drug administration. We will explore these
psilocybin-driven changes in behavioral states and motivated task acquisition and identify the cellular and
brainwide substrates, from dendritic spines to large-scale brain networks.
Aim 1 examines the accelerated acquisition of motivated behavior components within an evidence
accumulation task. In preliminary results, psilocybin specifically enhances stages requiring changes in action
control rather than working memory capacity. Pharmacological studies so far show that ketanserin blocks
acute effects but preserves learning enhancement, while TrkB antagonist ANA-12 blocks learning
enhancement but not acute effects. Using transgenic mice lacking the TrkB allosteric site, we will next test
whether psilocybin's learning effects require action upon the neurotrophin pathway. Trial-by-trial and within-trial
analyses will quantify attentional state, sensory integration, and learning rate. In freely moving mice, we will
perform automated pose tracking to quantify social behavior and motivation.
Aim 2 identifies cellular and brainwide substrates of psilocybin-induced functional change. Our
preliminary data from mouse brain sections show that training combined with psilocybin leads to reduced
dendritic spine density specifically in task-relevant cortical regions, suggesting enhanced circuit refinement.
Using AI-based spine detection and in vivo multiphoton imaging, we will track spine dynamics over extended
periods. These methods will be applied to wild-type and TrkB-allosteric-knockout mice to evaluate whether
dendritic spine plasticity is co-regulated with learning acceleration. Using automated analysis of activity-
dependent neuronal c-Fos expression with light-sheet microscopy, we will further perform a brainwide
association study to identify regions and co-activated networks supporting enhanced task acquisition.
The "breakthrough therapy" status granted to psilocybin underscores its therapeutic potential. This
proposal seeks to advance our understanding of psilocybin's brain circuit-level mechanisms, with the goal of
developing interventions that preserve therapeutic benefits while minimizing unwanted effects. The results will
guide future neurophysiological investigations and more effective psilocybin-based treatments for mental
health concerns.

Public health relevance
PROJECT NARRATIVE This proposal seeks to investigate the systems-level neurobiological mechanisms underlying the therapeutic potential of psilocybin, which remain largely obscure amidst ongoing clinical trials in humans. Preliminary findings show that psilocybin works through two separate pathways, serotonergic causing immediate effects, and another enhancing learning ability, suggesting the possibility of developing new treatments that preserve therapeutic benefits while minimizing unwanted effects. By dissecting psilocybin-driven enhancements in behavioral states, social motivation, and motivated task acquisition, as well as identifying cellular and brainwide substrates using tracking of dendritic structural plasticity and brainwide neural activity, this exploratory investigation will contribute to the optimization of psilocybin-based interventions for mental health concerns.